Molecular pathways connecting sleep, stress, metabolism and longevity

Project Summary/Abstract
Genetic screens in Drosophila have identified mutations that significantly reduce both night-
time and daytime sleep. Genes affected by these mutations are expressed in the blood-brain-
barrier-forming subperineurial glia of the fly and alter the morphological and biophysical
properties of the barrier. We have discovered novel genetic interactions among some of these
mutations: surprisingly, certain mutant combinations restore both sleep and blood-brain-barrier
function. We propose further studies that could reveal molecular pathways connecting their
gene products and clarify their contributions to sleep and barrier function. We discovered that
in wild type Drosophila the blood-brain barrier opens and closes with a rhythm that requires a
circadian clock. We have also found that barrier permeability is closely connected to sleep
need: sleep deprivation opens the barrier, but rebound sleep closes it. What is being
exchanged across the barrier in such a dynamic fashion? Nervous system function is protected
by a steep concentration gradient of K+ separating the haemolymph and brain. In our proposed
studies we will develop tools to quantify K+ flux across the blood brain barrier with high temporal
resolution in living flies. Are episodes of sleep and wakefulness correlated with these ion
exchanges? Do such measurements reveal features of wake/sleep behavior that are not
evident using standard locomotor activity monitoring? Our studies have also shown that sleep
mutants reduce lifespan, but in a fashion that can be reversed by time-controlled access to
food. These effects require a circadian clock and we will determine which tissues are
responsible for this response and whether lifespan restoration depends on sleep recovery.
Chronic exposure to psychogenic stressors can have profound, long-lasting effects on both
physical and mental health and is often accompanied by a profound loss of sleep. Chronic
social isolation provides a means by which a psychogenic stressor can be easily applied for
an extended period, and we observe significant reductions in total sleep, day-time sleep, and
night-time sleep in isolated flies when compared to sleep in siblings that are group reared. To
search for genetic pathways that might respond to isolation-induced stress and depress sleep,
comparative RNAseq assays were performed using Drosophila heads collected from group-
reared flies, or from flies stressed through chronic isolation. Among the most highly responding
genes are those thought to regulate appetite. These map to a small neuronal circuit which we
will further characterize to determine its possible role in isolation-induced stress responses
affecting sleep and hunger.

Public health relevance
Project Narrative Sleep disorders have a major clinical and economic impact in the U.S., with 10-15% of the U.S. population suffering from chronic insomnia. Molecular genetic studies that began in Drosophila have already allowed mutant orthologs of Period proteins, casein kinase 1, and Cryptochromes to be connected to certain inborn errors of human sleep including familial forms of advanced sleep phase and delayed sleep phase disorders. Given the impact of these earlier contributions, we believe our proposed genetic, cellular, and biochemical studies of Drosophila will continue to provide tools and discoveries relevant to our understanding of human sleep.